Function of PfNCR1 at the PPM/PVM Interface

Summary
Niemann-Pick C1-related protein 1 (PfNCR1) is a cholesterol (CHL) transporter that is of
great interest as an antimalarial drug target. PfNCR1 resides in regions of the parasite
plasma membrane that are in contact with the parasitophorous vacuolar membrane that
surrounds the malaria parasite inside its host erythrocyte. It is believed that this
transporter defends the CHL-poor plasma membrane from CHL accumulation by pumping
CHL out. We have recently obtained a cryo-EM structure of PfNCR1, alone and in
complex with a small molecule inhibitor. The structures reveal a CHL tunnel that appears
to be blocked by inhibitor. Other known inhibitors are predicted by molecular modeling to
block CHL movement through the tunnel. We have identified two new PfNCR1 inhibitors
that are predicted to bind away from the tunnel region and are putative allosteric inhibitors.
We propose to characterize the mechanism of inhibition of PfNCR1 by these interesting
new inhibitors, using structural, physiological, genetic and cell biological approaches.
We recently described a region of contact between the parasite plasma membrane and
parasitophorous vacuolar membrane in a study of PfNCR1 localization. We proposed that
the contact sites could be where hydrophobic solutes are transported, in contrast to the
regions where there is a substantial vacuolar space between the two membranes,
wherein the protein export machinery resides. Little is known about the region of
apposition. Our goal is to take advantage of the PfNCR1 localization to explore the
components of this zone. Preliminary proximity biotinylation experiments have shown a
number of transporters in proximity to PfNCR1. We propose to study these associations
by protein biochemistry and structural studies. The goal is to develop a better
understanding of components and interactions in this membrane contact zone, to inform
us about function of the region.
We anticipate that the proposed studies will give us new insights into an important cellular
transporter, PfNCR1, its inhibition, and its function in the unexplored region of apposition
between the two membranes that surround the malaria parasite. The proposed work is a
terrific collaboration between the cell biology/biochemistry group of Dr. Daniel Goldberg
and the structure/physiology group of Dr. Ed Yu. This collaboration is already underway
and functioning beautifully. This grant aims to keep this work moving forward.

Public health relevance
Resistance to antimalarial drugs necessitates the search for new drug targets. PfNCR1 is a promising target protein that is essential for cholesterol handling in the malaria parasite. This project is aimed at understanding how this protein works in the cell and how we can inhibit its function to make a new drug for malaria.